Influence of neuromelanin on single dopaminergic neurons in Parkinson's disease.

Dopamine neurons in the substantia nigra pars compacta (SNc) are exquisitely susceptible to degeneration
and are responsible for the cardinal motor symptoms of Parkinson’s disease (PD). All currently available
treatments for PD such as L-DOPA focus on symptoms, and none of the promising results from preclinical
studies have translated to a single disease-modifying therapeutic agent. In humans, catecholaminergic
neurons, including dopamine neurons in the SNc, specifically express the dark brown pigment neuromelanin
and are among the most sensitive neurons to degeneration in PD. Neuromelanin accumulation is not observed
in rats and mice, thus the cellular and systemic effects of neuromelanin accumulation in dopamine neurons are
not currently understood. We have recently developed and validated the first Cre-dependent adeno-associated
virus (AAV-DIO-hTyr) that can be used to express the human tyrosinase enzyme specifically in dopamine
neurons of dopamine transporter (DAT)-Cre mice. Preliminary results indicate that following virus injection,
dopamine neurons progressively accumulate neuromelanin, producing disrupted cellular physiology, PD-like
motor impairment, and ultimately catastrophic dopamine neuron cell death. This project will leverage the
expertise of three established labs with deep experience studying neurodegenerative disease,
catecholaminergic neurons, electrophysiology, and neuroinflammation to explore neuromelanin accumulation
in this novel mouse model. The hypothesis to be tested is that progressive neuromelanin accumulation disrupts
cellular physiology, neuritic morphology, behavior, and ultimately causes neuroinflammation and cell death.
Experiments in Aim 1 will delineate the anatomical and behavioral consequences of neuromelanin
accumulation in dopamine neurons from mice that have and have not been exposed to L-DOPA. Experiments
in Aim 2 will use patch clamp electrophysiology to determine the effects of neuromelanin on neuronal
excitability in the SNc and the adjacent ventral tegmental area (VTA), which is somewhat protected in PD.
Results will be assessed by time point and level of neuromelanin accumulation in single neurons. Experiments
in Aim 3 will use Patch-sequencing to correlate electrophysiological findings with molecular phenotypes in
single dopamine neurons following neuromelanin accumulation and L-DOPA treatment. Astrocyte and
microglia will be also tested for inflammatory and disease-related phenotypes in the midbrain and also the
striatum, the main terminal field of dopamine neurons. Results will be compared to other models and
postmortem data from PD patients. These studies will be the first to explore the distinct factors introduced by
neuromelanin accumulation and L-DOPA treatment in mouse dopamine neurons. Results will fill a key
knowledge gap in the PD field and inform ongoing and future studies into PD pathogenesis that could be
transformative.

Public health relevance
Disease-modifying treatments for Parkinson’s disease do not currently exist, possibly due to weaknesses in the rodent models typically used for preclinical studies. This project will leverage a novel mouse model of neuromelanin accumulation in dopaminergic neurons to overcome a key difference between human and rodent brains that could contribute to disease pathogenesis. Results will provide a wealth of information in susceptible cell populations with direct relevance to Parkinson’s pathology, informing the design of future experiments into novel therapeutic targets.